ANTI COAGULATION ON ASSESSMENT OF ABCIXIMAB INDUCED PLATELET INHIB

The primary objective of this study is to assess the effect of three anticoagulans (sodium citrate, heparin and PPACK) on the assessment of platelet inhibition induced in-vitro by GP IIb/IIIa antagonist. Platelet function will be assessed by platelet-rich plasma (PRP) aggregation, whole blood aggregation, platelet GP IIb/IIIa receptor occupancy, and platelet-adhesion.